An Ultra-Thin Steerable Transnasal Endoscope to Replace Exploratory Middle Ear Surgeries

Project Summary/Abstract:
The objective of this proposal is to create a new low-cost, needle-sized steerable endoscope that makes it
possible to survey and diagnose middle ear disease using a minimally-invasive trans-Eustachian tube approach,
sparing patients from invasive surgery.
Clinical signiﬁcance comes from the 84,000 surgeries per year (in the USA alone) performed on patients who
suffer from a middle ear disease called cholesteatoma that requires exploratory surgery for diagnosis, which is
currently achieved surgically by lifting the eardrum to expose the middle ear space. Surgery is currently the only
deﬁnitive way to diagnose these patients. Worse yet, a second surgery is performed to check for recurrence
a year later – even though 67% of patients will be disease free at that time. We seek to replace surgical
inspection with a simple endoscopy, facilitated by our new ultra-thin steerable endoscope passed through the
Eustachian tube. Our central hypothesis is that our new trans-tubal endoscopic approach can achieve diagnostic
visualization of the middle ear equivalent to that provided by surgery today. This has the potential to spare many
patients from the pain and complications associated with surgery, by replacing it with a simple endoscopy done
through the nose.
Innovation comes from harnessing elastic interactions in asymmetrically stiff, thin-walled tubes to create a
steerable endoscope that is (1) small enough to pass through the Eustachian tube, while (2) carrying a tiny
camera and optical illumination ﬁbers within its own central lumen. The small diameter of the Eustachian tube
precludes the use of bulky standard endoscope steering mechanisms. Instead, we harness stiffness asymmetry
encoded into the material properties of two tubes that are attached at their tips, thereby transforming small axial
motions applied at the endoscope handle into dexterous local bending at the endoscope tip. The result is an
inexpensive, needle-sized, disposable, steerable endoscope for trans-tubal visualization of the middle ear.
Our approach in Aim 1 is to use laser micromanufacturing and catheter-inspired design processes to fabricate
a clinic-ready steerable endoscope tip with integrated imaging and illumination. Aim 2 incorporates rigorous
quality and human factors-based design enhancements, preparing our device for FDA 510(k) clearance review
immediately at the end of Phase II. Aim 3 focuses on statistically powered experiments to evaluate our hypothesis
that our new steerable aiming tip will enable middle ear inspection and cholesteatoma diagnoses to be performed
using a non-surgical, trans-Eustachian tube approach, with equal diagnostic-quality visual coverage compared
to the surgical standard-of-care. Success in validating these hypotheses will strongly motivate future Phase III
activities (supported by private capital after the conclusion of this Phase II SBIR) where we complete the FDA
510(k) clearance process, and launch our device on the market.

Public health relevance
Narrative: Public Health Relevance At any given time, 1 in 20 people in the United States suffer from middle ear disease, and optimal diagnosis requires visual inspection due to a lack of externally visible symptoms. Because the disease lies behind the eardrum, direct visual inspection is currently achieved surgically. We propose a new, ultra-thin, steerable digital endoscope that can enable inspection in a minimally-invasive manner, entering through the patient's nose and passing through the Eustachian tube to access the middle ear in a non-surgical way. This device has the potential to provide accurate diagnoses and eliminate the need for invasive exploratory surgery for many patients suffering from middle ear disease.